Genetic variation influences the severity of urinary tract infections and subsequent immune responses in the bladder and remote tissues in the collaborative cross mouse model

Summary:
Immunogenetics is the study of the genetic basis of the immune response and has significant potential
to provide insight into health and disease. Initial insights have come from studying circulating peripheral
immune cell populations and correlating these cells with clinical outcomes, however immune cells vary across
tissues and some cell types including macrophages can only be found in tissues and not in the circulation.
Regulation of the tissue specific immune response is complex and involves multiple molecular
mechanisms. Tissue specific immunity is significantly influenced by the secretion of cytokines and growth
factors by tissue specific cells. Utilizing the inbred mouse model has allowed scientists to evaluate these
regulators of tissue specific immunity, as mice and humans share 99% of genes. One significant advantage of
the inbred mouse model is availability of numerous immunological tools including gene knock-out and gene
knock-in that can be employed to identify the role of a specific protein in immune pathways. However, the
genetic variation found in humans results in a variety of individualized immune responses to infectious and
autoimmune diseases, and this cannot not be captured in the traditional inbred laboratory mouse model. In
contrast, the genetically diverse collaborative cross mice have permitted the application of genetic approaches
to study the diversity of tissue specific immunity in the lung and have identified genes associated with infection
resistance, susceptibility, and severity. However, this approach as not been applied in the field of urology,
bladder immunity and to urinary tract infections (UTI), one of the most common bacterial infections.
UTI are predominantly caused by uropathogenic Escherichia coli which infect a healthy population with
incidence in women much higher than in men and nearly half of all women have reoccurring UTIs. Currently,
mechanisms for the high rates of reoccurrence and severity are unknown, albeit genetics and immunity must
play an important role in controlling UTI. There have been some focused studies that have identified a few
genes that lead to either increased resistance or susceptibility to UTI. However, the immunogenetics of the
bladder and kidney in the steady state and during a UTI is less well studied at the genome wide scale.
This project will use the collaborative cross mice in order to evaluate the heterogenicity of UTI and the
subsequent immune responses, more accurately mimicking observations made in the human population. We
will evaluate the immune response in the bladder and remote tissues (including the kidney, spleen, and brain)
that may give insight into UTI complications and comorbidities. Using the publicly available whole genome
sequencing data we will identify quantitative trait loci and genes associated with the severity, susceptibility, or
resistance to UTIs and bladder macrophage immunoregulation. Our work will define novel subsets of
macrophages, differentially activated in the diverse collaborative cross mice. Furthermore, these results will
inform the selection of additional strains of mice to be used in further investigation of UTI pathogenesis.

Public health relevance
Narrative: Successful completion of the proposed study will enhance our knowledge of the role genetic variation has on the resistance, susceptibility and severity and subsequent immune responses to urinary tract infections. The results gained from this project will identify candidate genes associated with UTI susceptibility and resistance and inform the selection of novel strains of mice to be used in further investigation of UTI pathogenesis. This will provide knowledge that can translate these novel discoveries into clinical applications.